Training and Career Development Core

The Training Component of the Immune Mediated Disorders after Allogeneic HCT Consortium will award a minimum of $50,000 annually to support career development for young investigators with an interest and aptitude for research in this field. Additional funds may be available from institutional resources committed to the PI, and at least one trainee will be supported each year. Trainees will be selected for financial support through an application process that will encourage women and minority candidates to apply. Additional career support will be available through the Consortium including access to data and specimens, participation in ongoing or planned studies, and funds for pilot projects conducted by mid-career investigators interested in reorienting their careers to study rare diseases. Trainees will also have access to training courses locally through the General Clinical Research Centers (GCRC), Clinical and Translational Science Awards (CTSA), Schools of Public Health or other coursework. Several week-long intensive courses supported by professional societies with relevance to the study of immune mediated disorders are also available. Potential mentors at each institution have been identified. Their letters of support and biosketches are provided.

Public health relevance
The purpose of the Training Component is to expand the number of qualified independent investigators involved in clinical or laboratory research in Immune Mediated Disorders after Allogeneic HCT.